Sex separation through targeting of conserved female-specific lethal genes in disease vector mosquitoes

Project Summary
Female mosquitoes differ from males in morphological, physiological, and behavioral traits that promote
the spread of disease-causing pathogens. Although the majority of genes that regulate sexually dimorphic
development in mosquitoes have not yet been identified, these genes may represent novel targets for
mosquito control. Characterization of female-specific developmental genes could also elucidate genetic
strategies for production and sorting of male mosquitoes, an obstacle that hinders global implementation of
several emerging population-based mosquito control strategies that are dependent on mass releases of males.
Clusters of loci that cause sex-specific lethal effects are believed to reside within the sex-determining M/m
locus region of the dengue vector mosquito Aedes aegypti, but the identities of these genes were not
previously known. A recent high-throughput RNAi-mediated screen uncovered female-specific larval lethal
genes in the A. aegypti sex-determining locus region, including several genes with known orthologs in other
species of disease vector mosquitoes. Yeast interfering RNA larvicides that target these genes kill female A.
aegypti larvae during development, but do not impact male mosquitoes. The proposed research program will
test the hypothesis, which is supported by preliminary data, that orthologs of these genes also function as
female-specific larval lethal loci in Aedes albopictus (vector of multiple arboviruses), Anopheles gambiae
(malaria vector), and Culex quinquefasciatus (West Nile and lymphatic filariasis vector). Specific aims of the
proposed investigation include i) RNAi-mediated screening of prospective female-specific lethal genes in these
disease vector mosquitoes, ii) construction and down-selection of female-specific yeast larvicides to target the
genes in each species, and iii) development of protocols for yeast larvicide-based mass rearing of fit, mating-
competitive male mosquitoes of all three species. It is anticipated that these studies will generate novel
female-specific larvicidal control strategies, provide insight into the evolution of mosquito sex chromosomes
and sex-specification mechanisms, and elucidate methodology for mass rearing of males that will facilitate
emerging population-based control strategies in multiple species of human disease vector mosquitoes.

Public health relevance
Project Narrative Female mosquitoes differ from males in morphological, physiological, and behavioral traits, such as blood feeding behavior, that promote the spread of disease- causing pathogens. The proposed research program will examine genes that are required for female mosquito survival during development. These studies will identify new genetic targets for vector control and facilitate global implementation of emerging population-based mosquito control strategies.